PERICYCLIC REACTIONS FOR ORGANIC SYNTHESIS

This proposal focuses on the application of pericyclic reactions in new methodology for the synthesis of several important classes of carbocyclic and heterocyclic organic compounds. Part I describes the development of new strategies for the synthesis of five- and six- membered aromatic, heteroaromatic, and dihydroaromatic systems. Intramolecular [4+2] cycloaddition reactions of conjugated enzymes will be investigated and employed in new routes to highly condensed polycyclic systems. Heterocyclic variants of this process will be developed leading to substituted pyridines, dihydroisobenzofurans, and isoindoles. The application of this chemistry to the synthesis of pentacylic polyketide marine natural products with protein tyrosine kinase inhibitory activity and to the synthesis of the antiviral agent nothapodytine B (mappicine ketone) will also be examined. Part II of the proposal describes the application of a tandem propargylic rearrangement-asymmetric inverse electron-demand intramolecular vinylallene Diels-Alder strategy in an exceptionally concise approach to the total synthesis of the nematod hatching stimulus agent glycinoeclepin A. Part III of the proposal describes the development of a new method for the synthesis of (trialkylsilyl) vinyl- and alkynylketens and application of these compounds in new cycloadditions processes leading to five- and six-membered carbocyclic and heterocyclic compounds.